SERVICES FOR NEW EFFORTS IN ENVIRONMENTAL EPIDEMIOLOGY

This contract was developed to provide support services to the NIEHS intramural epidemiological research program. The contractor's responsibility is to provide support for the design and conduct of a series of epidemiological studies, which may include abstracting records, designing questionnaires, managing field and telephone interviewing, collecting biologic and environmental specimens, tracing respondents and managing large-scale data preparation and analysis. To date, studies have been initiated in the areas of Sister Chromatid Exchange in Smokers and Non-smokers, Sister Chromatid Exchange in Taiwan, Smoker's Hormones, Long-Term Effects of Adjuvant Chemotherapy for Breast Cancer.